Co-Use of Opioid Medications and Alcohol Prevention Study (COAPS)

PUBLIC HEALTH ABSTRACT
Co-use of alcohol and opioid medications is known to be a serious health/safety hazard—yet persists
despite these negative ramifications. With limited information available within peer-reviewed literature, large-
scale system and clinical research have demonstrated 24-38% of those with alcohol use disorders also have an
opioid addiction, with rates of past 30-day opioid medication misuse among those seeking alcohol treatment as
high as 68%. Our research has shown that among community pharmacy patients receiving opioid medications
for pain management, approximately 20-30% are engaged in co-use of alcohol. Community pharmacy is a highly
valuable but underutilized resource and setting for identification and intervention to address the US opioid epi-
demic. We propose to adapt, manualize, and test the acceptability, feasibility, and preliminary efficacy of an
Alcohol-targeted Brief Intervention-Medication Therapy Management (ABI-MTM) intervention with community
pharmacy patients. ABI-MTM will be a pharmacy-based medication management intervention, combined with
Screening, Brief Intervention, and Referral to treatment that will target: (1) alcohol use elimination during opioid
treatment OR (2) non-opioid pain management substitution (in consultation with the prescriber). We will conduct
a small-scale trial in 3 community pharmacy locations wherein we will randomize patients with heavy alcohol use
and with non-heavy alcohol use (1-to-1 ratio) to ABI-MTM (n=20) or standard medication counseling (SMC,
n=20). Results will demonstrate intervention acceptability, feasibility, and preliminary efficacy. This study will also
work to identify pharmacy system and practice-level barriers and facilitators for universal alcohol screening and
intervention among opioid recipients. We will develop a mixed methods assessment guide to interview pharmacy
technicians (N=20), pharmacists (N=20), and corporate leaders (N=20). Interviews will assess perceptions to-
wards screening/intervention, internal organizational challenges, and processes related to ABI-MTM implemen-
tation for large-scale research and practice. Altogether, results of this study will provide critical insights, founda-
tional data, and strategies for executing a powered trial and possible future system/practice-level implementation.

Public health relevance
NARRATIVE Previous research, including that of our team, shows that a significant portion of those regularly using opioids—particularly filling opioids at community pharmacies—also are involved in the co-use of alcohol. This study proposes to adapt a previously developed intervention for opioid medication misuse; test its acceptability, feasibility, and preliminary efficacy; and identify barriers and facilitators to large-scale research and system-level implementation. Results of this study will directly inform a fully-powered subsequent multisite trial.